IGF::OT::IGF IMPROVE COMPLETENESS OF TREATMENT AND OTHER KEY DATA ELEMENTS BY LINKAGES WITH 15-MONTH RESUBMITTED DATA FROM COMMISSION ON CANCER HOSPITALS

This RRSS study will allow a thorough evaluation of the value of obtaining updated information from resubmitted hospital data. Objectives: 1) To examine major cancer types (lung, prostate, melanoma, kidney/renal pelvis, pancreas, bladder and NHL, as well as breast and colorectal cases) to see how updated data can increase details about the case as to treatment and other factors. 2) To conduct an in depth evaluation of how treatments changed from “none” to a known treatment, and of treatments updated with a more extensive or specific treatment code adds to the totality of the case information available. Frequency and types of treatments will be examined as will updates to staging and diagnostic/prognostic information.